Clarifying the overlapping pathology of delirium and dementia

Project Summary
Dementia is a leading cause of death in the United States and is associated with loss of quality of life and
independence; it cannot be prevented, or cured. Delirium is a sudden state of confusion that is associated with
increased morbidity and mortality and impaired long-term cognition. Both delirium and dementia are bereft of
therapies, largely due to the limited understanding of their pathogeneses. The vulnerability of people with
dementia to experience delirium offers a unique opportunity to understand their overlapping pathology and to
identify new therapies. It has long been thought that changes in the neurotransmitter acetylcholine cause
delirium, because drugs that inhibit acetylcholine can cause a state of confusion that resembles delirium. In
Aim 1, we will measure electrical activity in the brain that is affected by acetylcholine. Demonstrating that
changes in this electrical activity correspond with the onset and resolution of delirium would strengthen the
cholinergic deficiency theory of delirium. However, changes in acetylcholine alone do not explain the various
symptoms caused by delirium or why different people develop different symptoms. In Aim 2, we will determine
whether changes in the neurotransmitter noradrenaline explain these differences, clarifying the overlapping
pathology of delirium and dementia. Alzheimer’s disease and related dementias accumulate abnormal tau
proteins in a small region of the brain called the locus coeruleus early in the disease. The locus coeruleus
controls noradrenaline signaling throughout the brain, and plays important roles in arousal and attention. When
severe inflammation stresses the body, damage to the locus coeruleus may lessen the release of
noradrenaline and predispose the person to hypoactive delirium. On the other hand, in the absence of early
dementia pathology a robust release of noradrenaline may predispose towards hyperactive delirium.
Understanding the role of noradrenaline in these different types of delirium could guide new targeted therapies.
Further, noradrenaline regulates metabolism in the brain by stimulating the release of lactate from astrocytes to
support nearby neurons. Some regions of the brain are less able to respond to the effects of noradrenaline,
potentially making them vulnerable to metabolic insufficiency. In Aim 2, we will determine whether these brain
regions are vulnerable to delirium by measuring the location and severity of slow wave electrical activity across
the brain. In Aim 3, we will determine whether these brain regions are vulnerable to injury and long-term
damage following surgery. Again, understanding whether metabolic insufficiency contributes to delirium and
long-term injury could guide targeted preventative therapies in vulnerable patients.

Public health relevance
Project Narrative Delirium and dementia are bereft of therapies, largely due to the limited understanding of their pathogeneses. The vulnerability of people with dementia to experience delirium offers a unique opportunity to understand their overlapping pathology and to identify new therapies. We will determine critical mechanisms of delirium subtypes, recovery and their contribution to long-term neurodegeneration.